Electrochemically generated microenvironments of oxygen and reactive oxygen/nitrogen species in extracellular medium

Project Summary
The spatiotemporal heterogeneity of extracellular environments is ubiquitously critical for the metabolism and
physiology of prokaryotic and eukaryotic organisms. Yet our tools for the spatiotemporal creation and/or
perturbation of microenvironments are currently limited. Controlling microenvironments in the extracellular
medium is particularly challenging for unstable reactive species, such as reactive oxygen and nitrogen species
(ROS and RNS), because the classic method of dosing ROS and RNS donors cannot provide a constant
ROS/RNS concentration and is unable to develop spatial gradients/microenvironments at microscopic scale to
fully mimic many in vivo conditions. Such difficulties of designing and programming spatiotemporal
microenvironments impedes more in-depth understandings towards single-cell microbial metabolism/physiology
as well as subcellular metabolic responses for eukaryotic systems.
We envision that selective biocompatible electrochemistry are capable of addressing these challenges by
generating or consuming biologically important species, such as O2 and ROS/RNS, directly in the extracellular
medium. We hypothesize that selective biocompatible electrochemistry will create spatiotemporal O2 and
ROS/RNS profiles otherwise difficult to achieve and advance our understanding of biological systems in a
spatially and temporally well-defined manner. This proposal outlines our overarching approach to develop and
deploy programmable spatiotemporal O2 and ROS/RNS microenvironments primarily for platforms compatible
with fluorescence microscopy. To achieve our vision, we will understand organisms’ metabolic responses towards
electrochemically active materials in biological medium. We will design selective electrochemical transformations
while keeping the electrochemistry biocompatible. Furthermore, we will develop O2 and ROS/RNS
microenvironments generated by electrochemistry and deploy such microenvironments to study single-cell
metabolism/physiology of infectious bacteria as well as metabolic responses at subcellular level.
The proposed research adopts a transdisciplinary approach integrating inorganic/materials chemistry,
electrochemistry, metabolomics, microbiology, cell biology and wearable electronics, thanks to the
multidisciplinary expertise of the PI and collaborators’ team. Successful development from the proposed research
will enrich our tools of perturbing extracellular microenvironments under conditions compatible with
characterization platforms such as fluorescence microscopy. It will enable researchers to understand biomedical
systems with higher spatiotemporal precision.

Public health relevance
Creating spatiotemporally well-defined microenvironments is challenging yet necessary to advance our understanding of many biomedical phenomena in both prokaryotic and eukaryotic organisms. We will address this challenge by using electrochemistry for the establishment and perturbation of such microenvironments, particularly for oxygen (O2), reactive oxygen and nitrogen species (ROS/RNS). Our work will enable researchers to study biological systems with higher spatiotemporal precision at single-cell if not subcellular levels.